Neurobehavioral mechanisms of social isolation and loneliness in serious mental illness

Summary
Some of the most debilitating and detrimental aspects of serious mental illnesses (SMI) are the 1) social isolation
(low numbers of social contacts) and 2) the subjective experiences of social disconnection (loneliness) that
frequently accompany these conditions. Social isolation and loneliness have an immense impact on day-to-day
functioning in SMI and are associated with an overall poor quality of life and early mortality. Currently there are
no available interventions that can prevent or reverse these devastating consequences of SMI. This may be in
part because the underlying neural and psychological mechanisms of social isolation and loneliness in SMI are
poorly understood. However, recent clues from studies employing advanced neuroimaging and digital
assessment approaches can provide the basis for a new approach to investigating such mechanisms. Prior work
has indicated that objective isolation and loneliness are correlated but also somewhat independent. Recent
neuroimaging findings support this model, revealing that social isolation and loneliness have both shared and
distinct neural correlates. However, it is also clear that these are not static phenomena; smartphone-based
assessments have revealed transient, dynamic changes in social isolation and loneliness. Individual differences
in the anticipation of rejection are associated with momentary experiences of loneliness, greater avoidance and
subsequent increases in social isolation. Thus, in the current proposal, we plan to comprehensively measure
both the relatively stable neural and behavioral predictors of social isolation and loneliness, as well as the
moment-to-moment changes in these experiences, in 60 individuals with SMI and 60 without SMI. In Aim 1 of
the proposed project, we will show that the higher levels of social isolation and loneliness in SMI are linked to
shared and distinct neural responses to social stimuli, with lower responses of social perception-related circuitry
(medial temporal lobe regions) linked to social isolation, and lower responses of reward-related circuitry (basal
ganglia regions) linked to loneliness. In Aim 2, we will measure transient changes in social isolation and
loneliness with smartphone assessments using a longitudinal “burst” design. Lastly, in Aim 3, we will determine
how the correlates of social isolation and loneliness identified in Aims 1 and 2 are linked to each other and to
levels of functioning, and measure the stability of these associations over time. Therefore, in this project, we plan
to demonstrate that fundamental neural and behavioral processes drive momentary variation in the experience
of social isolation and loneliness, and directly impact functioning and quality of life in SMI. In follow-up work,
these findings can be used as quantitative targets in studies of novel interventions which aim to address these
major causes of disability and early mortality.

Public health relevance
Project Narrative The proposed research will test the hypothesis that objective social isolation and loneliness are linked to neurobehavioral mechanisms involved in social perception and motivation in individuals with and without serious mental illness. It will also investigate the specific dynamic interactions among these phenomena in daily life and how they, as well as the neurobehavioral predictors, are linked to day-to-day functioning. The findings of this project could provide novel targets for therapeutics aimed at improving functioning and overall quality of life in individuals with serious mental illnesses, as well as quantitative phenotypes for use in genetic investigations and early detection efforts.